Invasive trophoblast cell differentiation

PROJECT SUMMARY
In the early stages of human pregnancy, cells from the developing placenta, termed extravillous trophoblast
(EVT) cells, must interact with the uterus. In other species including the rat, this special class of trophoblasts are
generically termed invasive trophoblast cells. The interaction between invasive trophoblast/EVT cells and the
uterus results in the necessary remodeling of spiral arteries to meet the increased demand of blood flow and
oxygen during pregnancy. Once remodeled, these arteries will integrate into the uterus to function in transporting
nutrients and waste to and from the fetus through the maternal bloodstream. Importantly, differentiation into these
specialized trophoblast cell types requires suppression of pathways essential for maintaining the trophoblast cell
stem state and activation of the invasive/EVT cell differentiation program. In this project, we investigate roles for
the leukemia inhibitory factor (LIF) and signal transducer and activator of transcription 3 (STAT3) pathway in the
regulation of invasive/EVT cell development. Roles for LIF/STAT3 regulatory networks in human trophoblast
stem cell models are the focus of Specific Aim 1. In Specific Aim 2, we will leverage a Stat3 conditional rat model
to investigate STAT3 effects on the development and functionality of the invasive trophoblast cells at the uterine-
placental interface. Experimentation includes genome-wide analyses of the transcriptome and the chromatin
landscape. Completion of this research project will facilitate the discovery of molecular controllers responsible
for regulating invasive/EVT cell lineage as well as create a platform for understanding the pathogenesis of early
pregnancy loss. In addition, this proposal will provide the postdoctoral trainee with the mentorship, training, and
skills required to become a successful independent investigator dedicated to human fertility research.

Public health relevance
PROJECT NARRATIVE Central to the etiology of disease processes leading to early pregnancy loss, preeclampsia, intrauterine growth restriction, placentae abruption, and pre-term birth is abnormal development of the uterine-placental interface. Morphogenesis of the uterine-placental interface depends on differentiation and actions of the invasive/extravillous trophoblast cell lineage. Elucidation of mechanisms controlling invasive/extravillous trophoblast cell differentiation and its involvement in the development of the uterine-trophoblast cell interface will lead to the discovery of diagnostics for early detection of failures in the establishment of pregnancy and regulatory events that can be targeted for therapeutic intervention.